eAlign: A Patient Portal-based Intervention to Align Medications with What Matters Most

PROJECT SUMMARY
Older adults with Alzheimer’s disease and related dementias (ADRD) often take multiple medications and use
potentially inappropriate medications (PIM), placing them at increased risk of adverse drug events, drug
interactions, treatment burden, and mortality. Deprescribing (reducing or stopping medications that are harmful
or unlikely to be beneficial) can improve outcomes for people living with dementia (PLWD). The overarching
goal of this proposal is to refine and pilot an intervention in which ADRD care partners are identified in primary
care and provided with educational materials through the patient portal to engage them in deprescribing for
PLWD. We propose a multicomponent intervention, eAlign, which includes: 1) Facilitated patient portal
registration for both PLWD and care partners; and 2) delivery of a patient portal intervention to align medication
decisions with PLWD and care partners goals, provide care partner training in nonpharmacologic treatment of
behavioral and psychological symptoms of dementia, and reduce polypharmacy and PIM use. We propose the
following specific aims: In Aim 1, we characterize triadic interactions regarding medication use from two
complementary perspectives. In Aim 1a we assess how communication dynamics and characteristics of
PLWD and care partners affect uptake of deprescribing recommendations during consultation with a clinical
pharmacist. We qualitatively analyze content of 120 audiorecorded visits conducted as part of an ongoing,
pharmacist-led deprescribing intervention for PLWD and their care partners in primary care. In Aim 1b we
identify individual (PLWD) and contextual (health system, clinic, clinician) factors that affect use of the patient
portal for medication management among PLWD by examining uptake and use of the patient portal from date
and time-stamped electronic interactions of n=7,500 PLWD receiving primary care in two health systems. In
Aim 2, we iteratively refine the eAlign protocol through a user-centered design process involving in-depth
interviews with key stakeholders (n=15-20 patient-care partner dyads and 10-15 frontline staff, clinicians,
clinical informaticists and health system leaders) at both health care systems. In Aim 3, we will pilot the
resultant eAlign protocol with a total of 100 patient-care partner dyads at both health care systems to establish
feasibility, acceptability and preliminary efficacy for a future multisite cluster randomized trial. We will conduct a
two-group pilot randomized trial to examine feasibility of measuring two primary outcomes (total number of
chronic daily medications and rates of PIM prescriptions among PLWD) and one caregiver-reported secondary
outcome, the Family Caregiver Medication Administration Hassles Scale. This work will establish the
preliminary data, methods, and partnerships to undertake a multisite embedded pragmatic clinical trial of a
triadic-based behavioral intervention to promote patient and care partner engagement, foster care that aligns
with patients’ values, and promote improved health and well-being outcomes for PLWD and their care partners.

Public health relevance
PROJECT NARRATIVE Individuals with Alzheimer's disease and related dementias are at risk for side effects and health risks from taking multiple medications. Deprescribing by reducing or stopping medications that are potentially inappropriate or unnecessary can improve health and well-being outcomes for this population and their care partners. The proposed research will refine and test a patient-centered and pragmatic intervention in which care partners of patients with dementia are provided with educational materials through the patient portal to engage them in deprescribing.